Targeting neuronal Drp1-Fis1 interactions to mediate glucocorticoid-induced pathologies

Nearly 80% of adults report feeling high levels of stress in their daily lives. As chronic stress exposure is
associated with negative health outcomes, understanding the effects of this stress exposure is crucial to
preventing the development of downstream pathologies. Mitochondria are dynamic organelles that have
roles in a number of functions that are crucial for cell survival. One such function includes the synthesis and
release of glucocorticoids in response to stress exposure. Interestingly, glucocorticoids can also impact
mitochondrial function, with high levels inducing dysfunction and mitochondrial fragmentation. Mitochondrial
fragmentation has been shown to activate inflammasomes and increase levels of proinflammatory
cytokines, which have been linked to negative behavioral outcomes linked to stress. Mitochondrial
fragmentation relies in part on a fission factor called Dynamin-related protein 1 (Drp1) and its interactions
with its receptors on the mitochondrial outer membrane. While studies have shown that chronic stress
induces fragmentation, the precise interactions between Drp1, its receptors, and chronic unpredictable
stress remains unclear. Our studies will test whether chronic unpredictable stress induces excessive
mitochondrial fragmentation via the elevation of glucocorticoids that increase Drp1 recruitment to the
mitochondrial outer membrane in a receptor-specific manner. We will then examine whether disruption of
these specific Drp1-receptor interactions can prevent mitochondrial fragmentation and subsequent
inflammation and downstream behavioral alterations.